Clinical, Laboratory, and Data Management Core

ABSTRACT
The Clinical, Laboratory and Data Management Core (Core B) provides the infrastructure for ensuring consistent
acquisition of clinical data, samples and sample derivatives for the laboratory studies proposed in CRISP2.
Additionally, because significant experience and expertise resides in Core B(1-6), it will serve to validate and
disseminate new protocols for sample acquisition, processing or analysis should needs arise. Core B also serves
as the base for inflammatory cytokine endotyping assays that serve all projects in the proposal. To achieve these
goals, Core B encompasses three major components – clinical, laboratory and data management– that will
provide infrastructure, training and expertise. Although functioning as a de facto center since 2004, the core was
formally established in 2012 to support CRISP1. These services will be maintained to provide optimal support to
CRISP2, upgrading as necessary to continue providing comprehensive and integrated clinical, laboratory and
data management.